Stress resilience by natural rewards: neurocircuit mechanisms

Project Summary
Engaging in pleasurable pastimes (e.g., hobbies, sports, and other leisure activities) can improve mood and
reduce perceived stress, suggesting that these activities are an effective means to confer stress resilience.
Chronic stress is often unavoidable, making the development of strategies to enhance stress resilience a clear
priority for the prevention or amelioration of stress-related diseases. Since beneficial behaviors likely promote
stress buffering via activation of brain pleasure and reward circuitry, we have developed and characterized a
rat model of stress buffering using intermittent access to a natural reward, limited sucrose intake (LSI). LSI
reduces the adverse behavioral effects of chronic stress (e.g., diminished sociability and threat appraisal) and
decreases hypothalamic-pituitary-adrenocortical axis reactivity. The stress-buffering provided by LSI is
reproduced by a noncaloric sweetener and other naturally rewarding behaviors (sexual activity), but not by
intragastric gavage of sucrose, supporting that the stress-protective effects of LSI are primarily due to its
rewarding properties. Our preliminary data suggest that LSI acts by altering top-down regulation of the
basolateral amygdala (BLA) by the prelimbic medial prefrontal cortex (PL mPFC). In addition, BLA projection
neurons can be divided into multiple subsets based on their distinct efferent projection sites, and can play
distinct roles in BLA-related behaviors. Thus, while LSI reduces total stress-induced neuronal activation (cFos)
in the BLA, the impact on distinct BLA PN populations will likely underlie its role in stress resilience. In support
of this idea, LSI reduces post-stress cFos expression in the ventral hippocampus (vHPC) and increases it in
the anterodorsal bed nucleus of the stria terminalis (adBST) – two regions that have receive direct BLA input
and exert opposing effects on stress-related behaviors. This suggests that LSI may provide stress resilience by
reducing the activity of direct BLA-vHPC projections, and increasing the activity of direct BLA-adBST
projections. This proposal therefore uses the LSI model to test the hypothesis that chronic engagement in
naturally rewarding experiences promotes behavioral resilience to chronic stress by altering a stress-reward
neurocircuitry linking the mPFC, BLA, vHPC and adBST. The first aim tests the contribution of PL top-down
regulation of the BLA, while the second aim tests the contribution of specific BLA projections to the vHPC and
adBST. Chemogenetic (DREADD) technology is combined with a retrograde viral approach to obtain circuit-
specific modulation of neural activity. The effects of circuit manipulation (activation and inhibition) on sociability
and threat appraisal behaviors is assessed in the context of chronic stress and/or reward (LSI). This work has
important implications, suggesting the presence of endogenous neurocircuits for stress buffering that can be
recruited by engaging in naturally-rewarding behaviors. An improved understanding of these neurocircuit
mechanisms may be leveraged to develop therapeutic strategies that minimize the adverse effects of chronic
stress on mental health, and may guide the optimization of alternative interventions for stress relief.

Public health relevance
Project Narrative Engaging in pleasurable pastimes (e.g., hobbies, sports and other leisure activities) can improve mood and decrease feelings of stress, and this proposal seeks to understand how these positive events provide stress relief. Our approach uses a rewarding behavior (consuming small amounts of tasty food) to buffer the negative behavioral consequences (social withdrawal, reduced exploratory behaviors) of chronic stress. The work investigates the idea that altered activity in brain stress-reward circuits drives the stress-buffering effects of pleasurable behaviors, and provides new information that will be critical for generating strategies to enhance stress resilience.